CORE--DEVELOPMENTAL FUNDS

At MSKCC, Development funds are critical to scientific growth and research program planning. The development funds are used exclusively for the support of research programs of new, young investigators without prior peer-reviewed research support.